Peer recovery support for people experiencing homelessness with opioid use disorder

PROJECT SUMMARY / ABSTRACT
People experiencing homelessness (PEH) are disproportionately affected by the opioid overdose crisis, with
overdose rates up to 30-times higher than the general population. Medications for opioid use disorder (OUD)
substantially reduce mortality, but retention in treatment remains low. Identifying strategies to improve OUD
treatment retention in this population is crucial to enhancing recovery opportunities and reducing mortality.
Peer recovery support has shown promise in improving OUD treatment outcomes in the general population,
but research studying its effects has been limited by a lack of attention to vulnerable populations (e.g., PEH),
heterogeneity in the services provided, and lack of methodologic rigor in study design. This award addresses
all of these gaps and will advance the science of peer recovery support for the treatment of OUD among PEH.
Using a community-engaged framework and a mixed methods design, the investigators will (1) develop a peer
recovery support intervention to promote OUD treatment retention tailored to PEH by incorporating qualitative
findings from patient focus groups and national Health Care for the Homeless program key stakeholder
interviews into a consensus building Delphi process, and (2) pilot test the feasibility, acceptability, and fidelity
of the peer recovery support intervention to promote OUD treatment retention among PEH. The proposed
research complements the National Institute on Drug Abuse’s (NIDA’s) 2022-2026 strategic plan by addressing
two priority areas: advancing the science of recovery support and conducting research in real-world clinical
settings. This proposal also supports several cross-cutting priorities at NIDA: promoting collaboration with
community stakeholders, incorporating patient perspectives into intervention development, and reducing health
disparities. The principal investigator’s (PI’s) long-term career goal is to become an independent physician-
investigator with expertise in designing and testing interventions to improve the health and health care of
marginalized individuals with substance use disorders. Though the PI has a strong research foundation in
epidemiologic and health services research methods, she will need additional training in (1) community-
engaged research with populations disadvantaged by social determinants of health, (2) mixed methods
research, and (3) design and conduct of interventional clinical trials in real-world settings to successfully carry
out this proposal and achieve her long-term goals. To accomplish these training objectives and her proposed
research plan, the PI assembled an exceptional team of mentors, developed a comprehensive training plan,
and will leverage the research expertise and infrastructure at Massachusetts General Hospital, the educational
expertise of Harvard Medical School, and the clinical infrastructure and homelessness expertise of Boston
Health Care for the Homeless Program. The successful completion of the proposed research will position the
PI to submit an NIH R01 application to conduct a full-scale trial of a peer recovery support intervention to
promote OUD treatment retention among PEH and facilitate her goal of becoming an independent investigator.

Public health relevance
PROJECT NARRATIVE People experiencing homelessness have been substantially and disproportionately impacted by the opioid overdose crisis. Though retention in opioid use disorder treatment reduces mortality in this population, retention is suboptimal. In this proposal, the investigators will use a community-engaged approach to develop and pilot test a tailored peer recovery support intervention to promote opioid use disorder treatment retention among people experiencing homelessness.